Origin and function of atypical lymphocyte populations in inflamed tissue in SLE and RA

A high-resolution analysis of cells in inflamed tissue offers the possibility of uncovering previously
unappreciated pathogenic mechanisms and of identifying new therapeutic targets.
In this project, we will characterize age/autoimmunity associated B cells (ABCs) in kidney and synovium of
patients with systemic lupus and rheumatoid arthritis, respectively. We will explore their heterogeneity,
derivation, localization, and antigenic targets as well as their functional interactions with T cell subsets, most
specifically T follicular and T peripheral helper cells (Tfh/Tph). These efforts will provide a broad assessment of
the features and potential functions of this highly expanded B cell population in human autoimmunity.